High collagen density favors pro-tumorigenic prolactin actions in breast cancer

DESCRIPTION (provided by applicant): Prolactin (PRL) involvement in breast cancer progression is increasingly recognized, yet its actions are poorly understood. Clinically, circulating PRL levels and density of the extracellular matrix (ECM) alone are significant risk factors for breast cancer. In mouse models, PRL promotes mammary carcinomas that resemble aggressive luminal breast cancers in women, and increased collagen density promotes tumor metastasis and progression. Although recent studies are illuminating the contributions of the ECM to the physiological actions of prolactin, little is known about the functional relationship between ECM density and PRL signaling in breast cancer. Here, our goal is to elucidate the interaction between collagen density and PRL signaling in breast cancer progression. In this revised application, I will test the hypothesis that PRL and stiff collagen matrices interact to promote mammary tumorigenesis and progression via association of PRL receptors with beta-integrins and lipid rafts, driving tumorigenic PRL actions through the FAK-SFK-ERK1/2 pathway. Specifically, I will determine the molecular mechanisms that control the interactions between ECM density and PRL signaling in breast cancer cells in a defined in vitro system (Aim 1), and examine the interplay between collagen density and PRL signaling in the development and progression of luminal mammary tumors in vivo, using a PRL transgenic mouse with humanized PRL expression and a genetically modified mouse that mimics the elevated collagen density observed in a subset of women (Aim 2). Achievement of these aims will lead to a more complete understanding of the complex interactions between the ECM and prolactin in breast cancer. This will allow for an informed approach for the development of novel therapeutics that uncouple elevated matrix density from pro-tumorigenic signaling pathways. Achieving the scientific goals of this proposal is only the first step in developing into an independent academic research scientist. Taking advantage of the outstanding facilities, faculty and training opportunities at UW-Madison, as well as the mentorship of my sponsor, I also will grow as an independent investigator in the areas of critical thinking, communication, mentoring and responsible conduct of research. This fellowship will aid in my development as a cancer biologist so that I may establish my own research group to discover new therapeutic and preventative approaches to cancer and train future scientist in cancer and cellular biology.

Public health relevance
PUBLIC HEALTH RELEVANCE: Two major risk factors for breast cancer in women are prolactin exposure and breast density. By examining the mechanism and functional outcome of the interaction of elevated collagen density and prolactin in the progression of breast cancer, the results of the experiments proposed in this application will lead to an increased understanding of this important relationship and reveal avenues for the design of novel therapeutics. __SpecificAimsTextDelimiter__ Specific Aims The involvement of prolactin (PRL) in breast cancer is increasingly recognized, yet little is known about the interaction of PRL with other risk factors for breast cancer, specifically breast density. The goal of this proposal is to elucidate the functional relationship of PRL and collagen 1 extracellular matrix (ECM) density in the context of breast cancer, through investigation of the molecular mechanisms that lead to modulation of PRL signaling in vitro, and in vivo studies to test the outcome of the interaction of elevated collagen 1 density and PRL signaling in tumor progression. PRL initiates signals through a number of different pathways via its transmembrane receptor (PRLR), such as JAK2/STAT5 and MEK1/2-ERK1/2 kinases, yet subtle changes in the relative strength of these signaling pathways profoundly affect cell behavior (11). We have previously shown that PRL promotes tumor progression through the ERK1/2 signaling cascade, while the JAK2/STAT5 pathway promotes more differentiated tumors (11-13). Interestingly, stiff collagen matrices increase breast cancer invasive behavior, such as metastasis and in vitro invasion through a collagen matrix (14). Stiff collagen matrices also increase basal levels of phosphorylated ERK1/2 two-fold over a compliant collagen matrix in vitro (15). However, the effects of matrix stiffness on PRL signaling, and consequences for PRL actions in breast cancer development and progression have not been known. I have shown that stiff collagen matrices increase PRL-induced signals to ERK1/2 via the SRC-family kinase (SFK)/ focal adhesion kinase (FAK) pathway in breast cancer cells in a defined 3D collagen matrix in vitro, driving MMP-2 expression and activity, and inducing invasion. In contrast, compliant collagen matrices favor PRL signals to STAT5, augmenting formation of differentiated acini-like colonies, and do not permit PRL to induce MMP-2 expression or invasion. These results, describing most of the studies proposed in the original Aim 1, are now in press in the Journal of Biological Chemistry (16). Understanding the mechanism of interaction between the ECM and PRL signals is critical for developing therapeutics targeting pro-tumorigenic signaling pathways. Prior reports indicate that stiff collagen matrices increase FAK localization to distinct punctae (17). I have shown that PRLR and FAK co-localization is increased in stiff matrices, suggesting that increased PRLR localization in focal adhesions is a critical step in collagen density-induced changes to PRL signals. Integrins also localize to focal adhesions. PRLR and β1 integrin interact under physiologic conditions in the pregnant mammary gland, important for PRL signals to STAT5 (18, 19). However, their interactions in disease, such as breast cancer, remain unclear. In vitro studies of factors involved in tumor progression are critical for understanding basic mechanisms, but do not always translate to meaningful results at the organism level. We have generated a transgenic mouse that produces PRL locally in the mammary gland and forms diverse mammary ERα+ carcinomas that are rare in mouse models of mammary cancer. Utilizing these animals, I will examine the interaction of PRL and collagen density in breast cancer development and progression in vivo. To test the overall hypothesis that PRL and stiff collagen matrices interact to promote mammary cancer via association of PRLR with lipid rafts and β-integrins, driving PRL signals through the pro-tumorigenic FAK-SFK- ERK1/2 pathway, I propose the following specific aims: Aim 1: Establish the molecular mechanism by which high density collagen 1 increases pro-tumorigenic PRL signaling. To test the hypothesis that high density collagen 1 increases pro-tumorigenic PRL signals through increased association of PRLR and β integrins in lipid rafts, co-localization of PRLR with β integrins in lipid rafts will be examined. Further, we will examine the role of RhoA and Rac1 GTP-ases in regulating β integrin/PRLR interaction and signaling, and the role of β integrin activity and scaffolding in the up-regulation of pro-tumorigenic PRL signals in high density collagen 1. Aim 2: Establish the effect of ECM density on progression of PRL-induced luminal cancers. To test the hypothesis that increased collagen 1 density increases the ability of PRL to promote progression of mammary tumors, PRL-dependent tumor cell lines derived from murine PRL-induced tumors will be transplanted into mice that harbor a non-cleavable form of collagen-1-alpha-1 and examined for tumor characteristics and activated signaling pathways. The role of collagen density in the ability of PRL to induce tumor development will be analyzed by crossing heterozygous NRL-PRL mice with heterozygous Col1a1tmJae mice to create NRL- PRL/Col1a1tmJae females, which will be monitored for tumor incidence, latency, and aggressiveness. These experiments will reveal the functional interaction of the density of the collagen extracellular matrix and PRL signaling in breast cancer. They will help shed light on the complex biology of PRL actions in mammary gland biology and disease, and aid in resolving conflicting reports in the literature. Finally, these studies will lay the groundwork for future studies to explore PRL interactions with other oncogenic factors, as well as the interaction of the ECM with other oncogenic factors in breast cancer progression.